Sleep pathology and cardiac aging

PROJECT SUMMARY/ABSTRACT
Sleep is normally a period of biological rest and recuperation for the cardiovascular system. Inadequate or low-
quality sleep is known to increase the risk of cardiovascular disease (CVD). Increasing evidence also suggests
that cardiac aging is an important hallmark of CVD. Traditional sleep assessment is based on questionaries
that are known to suffer from limited resolution and existing biases. In addition, sleep quality is typically
measured at a single examination, which limits its capability to assess the impact of changes in sleep patterns
on cardiac health. Recent advances in digital technologies provide a promising solution to assess the impact of
sleep pathology on cardiac health longitudinally. We hypothesize that impaired sleep quality and sleep apnea
accelerate cardiac electrophysiological aging and increase the risk of cardiovascular disease. We will leverage
a rare longitudinal collection of objective sleep measures and cardiovascular health in the Korean Genome and
Epidemiology Study (KoGES). Our study will include ~2800 participants who have 3 cycles of overnight
polysomnography starting in 2011 and 4th cycle to be completed by 2025. Two specific aims will be pursued. In
Aim 1, we will assess the association of sleep apnea on aging cross-sectionally and longitudinally over 12
years. In Aim 2, we will determine if specific sleep and sleep apnea endotypes are associated with accelerated
cardiac aging. This investigation will provide critical knowledge to better understand the impact of sleep on
cardiac aging and cardiac health. Our long-term goal is to use sleep-targeted treatment as a way to preserve
cardiac function, preventing the inevitable deterioration with aging.

Public health relevance
PROJECT NARRATIVE Sleep is known to relate to general health but the effect of abnormal sleep on cardiac aging is yet to be fully determined. This proposal will take advantage of the longitudinal measure of sleep pathology in the Korean Genome and Epidemiology Study, a well-characterized cohort, and assess its impact on cardiac aging over one decade. The outlined strategy will identify novel digital sleep biomarkers and provide new avenues for future intervention to reduce the burden of cardiovascular disease.